Using STRAINS, a big data method that analyzes the spatiotemporal distribution of cell phenotypes, to investigate mechanotransduction pathways in injured cartilage

PROJECT SUMMARY
Osteoarthritis is a leading cause of disability in the US affecting almost 30 million people at an annual cost of
$128 billion. Initiation of osteoarthritis is tied to genetic predisposition, chronic overload, or acute injury due to
joint trauma. The development of osteoarthritis after acute injury is particularly prevalent with more than 50% of
injury developing full blown symptomatic osteoarthritis 10-20 years after injury. Despite the importance of this
topic and decades of research, the local mechanical events that occur in cartilage during tissue injury and how
they affect chondrocyte phenotypes and ultimately cell fate are still poorly understood. Importantly, developing
an understanding of the mechanotransduction response in cartilage tissue is confounded by the heterogeneity
of cellular responses arising from spatially complex strain fields induced during impact and the heterogeneity of
cartilage tissue itself. These factors indicate that to understand the coordination of mechanotransduction
throughout the tissue it will be critical to develop a framework capable of simultaneously analyzing the real time
response of multiple signaling pathways for thousands of cells distributed in locations throughout the tissue.
Recently, we developed a novel SpatioTemporal Response Analysis IN Situ (STRAINS) tool that combines in
situ real time measurements of chondrocyte behavior with big data machine learning analysis techniques to
provide a spatiotemporal map of cellular behavior throughout a tissue explant. In this proposal we take advantage
of this newly developed microscopy and image analysis techniques to determine the location dependent
distribution of cell phenotypes and how they change after an impact. Our aim is to use these techniques to probe
the peracute response of chondrocytes to impact trauma to more fully understand the processes that occur
during the very early disease process, and, more specifically, the effects that manipulating Ca2+ signaling or
protecting MT bioenergetics have on cell fate after joint injury. Such studies have the potential to identify a
window of opportunity for intervening in the disease process of post traumatic osteoarthritis, when disease
modification is still possible. The specific aims of the proposal are to: 1) Determine whether local peak strain
magnitude affects the distribution of cellular phenotypes similarly in the superficial and middle zones. 2)
Determine how altering known calcium dependent mechanotransduction pathways alters distribution of
phenotypes after impact. 3) Determine how altering mitochondria related cellular responses affects the
distribution of phenotypes after impact. The proposed work will develop an understanding of the mechanisms
that govern cell fate after traumatic injury. Identifying the specific cellular behaviors that accompany
hyperphysiologic loading will provide new targets for future therapies in post-traumatic osteoarthritis. Consistent
with an R21 mechanism, this work focuses on developing the model and experimental techniques on healthy
tissue. Future work will expand these methods to study diseased tissue ex-vivo and in-vivo using intravital
imaging in animal models.

Public health relevance
PROJECT NARRATIVE Osteoarthritis (OA), a disease that affects 30 million people in the United States, is characterized by a progressive degeneration of articular cartilage that is frequently initiated by joint trauma. To gain insight into the response of cartilage cells to injury throughout the tissue, we propose to measure and analyze, using a new large data and machine learning based technique, the real time response of cells throughout a cartilage tissue after it is impacted with an indenter. Understanding how the distribution of cell phenotypes is altered when the tissue is exposed to different impact strengths, or when specific calcium signaling or bioenergetic pathways are enhanced or suppressed will enable us to develop an understanding of the mechanisms that govern cell fate after traumatic injury and ultimately identify targets for interventions that could protect impacted tissue from further degradation.